DEVELOPMENTAL AND GENETIC DEFECTS OF IMMUNITY

The purpose of this project is to explore the natural history and mode of inheritance, carrier detection and prenatal diagnosis of immunodeficiency syndromes and to determine as precisely as possible the cellular and molecular defect responsible for abnormal immune responses.